Characterizing Regulatory Mechanisms Underlying Drug Resistance in Breast Cancer Using Keratin 19

PROJECT SUMMARY
Drug resistance continues to be the major limiting factor in achieving cures for cancer patients. In breast
cancer, cyclin-dependent kinases 4 and 6 (CDK4/6) inhibitors have been approved recently to treat patients
with advanced estrogen receptor-positive tumors. However, most patients exhibit resistance due to a lack of
predictive biomarker. Understanding the molecular basis underlying drug resistance is required to provide a
critical breakthrough in identifying a predictive biomarker and developing effective therapeutic strategies.
Based on our previous work and preliminary data, we propose that a cytoskeletal protein keratin 19 (K19),
which currently serves as one of the most reliable diagnostic and prognostic markers, regulates signaling
events to impact resistance against CDK4/6 inhibitors. We found that K19 binds to and inhibits a
multifunctional kinase GSK to stabilize a CDK4/6 partner cyclin D3 in breast cancer cells. K19-GSK3
interaction was associated with decreased accumulation of GSK3 in the nucleus that is crucial to GSK3
function. Moreover, K19 promoted proliferation and maintained the sensitivity of cells to CDK4/6 inhibitors. We
hypothesize that cyclin D3 stabilized by K19-dependent inhibition of GSK3 causes tumors to become
dependent on the CDK4/6 pathway for growth and sensitizes them to CDK4/6 inhibitors. At the molecular level,
we surmise that K19 filaments serve as cytoplasmic scaffolds for GSK3 to prevent its entry into the nucleus
where it phosphorylates cyclin D3 for degradation. To address our hypotheses, we propose to 1) determine
K19 effects on the GSK3 signaling network, 2) characterize the interaction between K19 and GSK3, and 3)
determine the impact of K19 on drug resistance and tumor growth. To this end, in Aim 1, we will identify
upstream regulators of K19-GSK3 interaction as well as GSK3 targets whose activities affect K19-
dependent phenotypes. In Aim 2, GSK3-binding deficient K19 mutant will be characterized to determine how
K19 interacts with GSK3 and affects the nuclear entry of GSK3. In Aim 3, we will assess how K19 affects
sensitivities of various breast cancer subtypes to CDK4/6 inhibitors and test the role of K19 and GSK3 on the
sensitivity of tumors to a CDK4/6 inhibitor in vivo. Upon successful completion, the knowledge gained from the
study can help design new drugs targeting K19-dependent signaling pathways, establish K19 as a predictive
biomarker for response to CDK4/6 inhibitors, and develop effective therapeutic strategies to combat drug
resistance.

Public health relevance
PROJECT NARRATIVE This project will examine the mechanistic details and biological significance of the novel interaction between a cytoskeletal protein and a multifunctional kinase. In the process, the project will address the mechanism underlying breast cancer growth and resistance to targeted therapy. The knowledge gained can help establish a new therapeutic target and predictive biomarker to develop effective therapeutic strategies.